Developing a Novel Incubator to Increase Cell Culture Reproducibility

Project Summary / Abstract
Embrient proudly presents its “Developing a Novel Incubator to Increase Cell Culture Reproducibility” grant.
For years, Embrient (and its predecessor company) has been addressing a problem bedeviling researchers
worldwide: “how can I culture my cells in a static, unchanging environment, instead of an environment that
changes unpredictably and potentially sabotages my experiment?”
Embrient's 50-year-old flagship product, the MIC-101, is a sealed incubation chamber that has admirably served
researchers investigating malaria, HIV, and even recent Nobel Prize laureates studying hypoxia-inducible factors
(HIF). The “flying saucer-shaped” chamber has been cited extensively in the scientific literature for over 50 years.
However, it has limited functionality and is somewhat difficult-to-use. Despite the MIC-101's proud history, the
time has come to replace it.
With this grant, Embrient aims to revolutionize incubator technology by developing a continuous flow
incubator that is virtually impregnable to typical outside perturbations, such as checking daily cell growth and
health, multiple users, contamination, and fluctuations in CO2, O2, and other gas mixtures. Embrient has
secured five patents for its pioneering incubator design that employs an "Air Veil" to insulate the interior
conditions from external influences.
A major issue coming from the NIH, researchers and incubator manufacturers alike has been, “how to increase
reproducibility of experiments over time and across labs?” Embrient's groundbreaking incubator directly
addresses this concern. Instead of “putting up with” currently marketed incubators that can take up to 50
minutes of “recovery time” after door openings and disturbances, Embrient's recovery time (subject to testing
and optimization to be performed in this grant), can be near zero.
To achieve this, Embrient will apply air barrier principles using laminar flow, already proven in large scale
applications such as commercial refrigerated (or heated) spaces, adapted to meet the unique needs of an
incubator.
This means cell culture experiments can achieve consistent human body and other conditions without the wide
fluctuations that plague current market incubators. Embrient can make a dramatic improvement in the way cell
culture is performed in laboratories worldwide, and thus make a major advance in research results.

Public health relevance
Narrative Embrient Inc is pleased to submit our request for an HHS / SBIR / NIBIB grant, entitled, “Developing a Novel Incubator to Increase Cell Culture Reproducibility.” By funding this grant, you will support our efforts to design and test an incubator that employs laminar flow principles, aiming to achieve zero or near-zero chamber recovery time when the incubator door is opened. This innovation holds the promise that future cell culture experiments utilizing our incubator can maintain stable conditions akin to the human body, without the extensive fluctuations that affect the reliability of current market incubators. As a result, research outcomes will be more dependable and reproducible, advancing scientific progress.